Role of the SWI/SNF complex in tumor suppression

Project Summary/Abstract:
A role for SWI/SNF complexes in cancer was first suggested when SMARCB1 was identified as
inactivated in virtually all malignant rhabdoid tumor (RT) cases, a highly aggressive pediatric cancer. It is now
clear that mutations in genes encoding subunits of SWI/SNF (BAF) chromatin-remodeling complexes are
frequent, collectively occurring in over 20% of all cancers. Our group established SMARCB1 as a bona fide
and potent tumor suppressor. We later made high-impact discoveries that helped define mechanisms by which
SWI/SNF mutations lead to dysregulated cell proliferation. Our findings suggest a model whereby SWI/SNF-
facilitated control of transcription underlies cellular fate specification, with disruption of this control being the
basis for cancer formation. Our long-term goals are to elucidate the function of SWI/SNF complexes, to
determine how their loss leads to oncogenesis, and to translate this knowledge into novel therapies.
Based on our findings, we hypothesized that loss of SMARCB1, while driving cancer growth, also
creates unique vulnerabilities. To identify such vulnerabilities, we collaborated with the Pediatric Dependencies
Project to perform a rigorous genome-wide CRISPR deletion screen involving 21 RT cell lines compared to
over 800 other cancer cell lines. Notably, rhabdoid tumors are typically diploid and contain few other mutations,
making them a powerful model with which to study the effects of gene deletions. We have now identified and
validated a novel gene that is specifically essential for rhabdoid cell survival from this screen. Our preliminary
data reveal that this gene's product, previously only linked to gene repression, has unanticipated connections
with SWI/SNF and transcriptional activity. We localize this protein to enhancers and promoters of genes bound
by SWI/SNF and hypothesize that this protein performs a key regulatory role in determining whether activating
SWI/SNF complexes or repressive complexes are recruited, thus serving a pivotal role in dictating cell fate.
We previously demonstrated that SWI/SNF and another repressive protein, EZH2, serve antagonistic roles
in chromatin regulation, a discovery that ultimately led to FDA approval of an EZH2 inhibitor (EZH2i) for
SMARCB1-mutant cancers. Despite this success, the mechanisms that control the interplay between these
complexes are poorly understood, as are the mechanisms that underlie resistance to EZH2i in SWI/SNF-mutant
cancers. To establish mechanisms driving drug resistance, we have performed a near genome-wide CRISPR
screen in EZH2 inhibitor-treated RTs. We previously identified NSD1 as a gene that, when inactivated, causes
resistance to EZH2i. Here, we plan to investigate the mechanism of resistance conferred by mutations in a
second chromatin regulatory gene not previously associated with SWI/SNF functions. Together, these
experiments have the potential for broad impact including understanding the roles of these critical chromatin
remodeling complexes in transcriptional control, in transformation, and as potential therapeutic vulnerabilities.

Public health relevance
Project Narrative: Genes encoding SWI/SNF complex subunits are mutated in over 20% of all human cancers, including the devastating childhood Rhabdoid Tumor. We have identified a gene that, when deleted, specifically kills rhabdoid cells. The proposed studies are designed to determine the normal function of this gene and the mechanisms by which its loss kills these cancers and, secondly, to explore novel approaches to circumvent therapeutic resistance in these aggressive cancers.